Morphological and molecular identification of Hyalomma tick vectors of Crimean-Congo Hemorrhagic Fever virus

Project Summary/Abstract
Ticks are obligate blood-feeders, temporary ectoparasites, and vectors of pathogens to humans and animals.
Certain species of the genus Hyalomma are the principal vectors of the virus that causes Crimean-Congo
hemorrhagic fever (CCHF), which poses a health risk in large territories of Europe, Asia, and Africa and fatal to
an estimated 30% of affected humans. Hyalomma species are also important vectors of pathogens causing
rickettsioses in humans and babesioses, anaplasmosis, and theileriosis in animals. The rationale for the
proposed research is that correct identification of tick species, particularly in the immature stages, is essential
for surveillance of vectors and pathogens, epidemiology, prevention, and treatment of tick-borne diseases.
However, identifying major Hyalomma species-vectors is challenging because the systematics of species
within groups of closely related species remains unresolved. Additionally, identification of species in the larval
and nymphal stages is almost impossible due to the lack of proper taxonomic works, identification keys, and
molecular diagnostic tools (e.g. real-time PCR assays).The overall objective of the proposed project is to
develop comprehensive tools (morphological and molecular) that effectively identify closely related Hyalomma
species that are vectors of CCHF virus. This will be achieved through two specific aims: (1) Resolve the
systematics within groups of closely related species of Hyalomma responsible for the transmission of CCHF
virus; such as H. marginatum (5 sp.), H. truncatum (3 sp.) and H. anatolicum (2 sp.), through: 1A) using
morphological data by examination of available specimens, illustration of diagnostic characters, and application
of multivariate statistics; and 1B) using both high throughput Illumina short read and Oxford Nanopore long
read genomic data, guided assembly and annotation, and coalescence-based phylogenetic analyses. (2) To
produce comprehensive morphological taxonomic keys and a molecular diagnostic tool for the identification of
closely related Hyalomma species-vectors of CCHF virus at each parasitic stage by: 2A) constructing fully
illustrated, web-based, interactive, multi-entry identification keys using morphological characters; and 2B)
using the genomic sequence data from Aim 1B to identify diagnostic gene or sequence regions for
development of a multiplex TaqMan probe based real-time PCR assay for the accurate identification of closely
related Hyalomma species. The impact of this research program is that it will develop effective identification
tools for Hyalomma species serving as major vectors of CCHF virus, through the integration of genomic,
morphological, host, and geographic information. These tools will be useful to healthcare providers and
scientists in numerous fields, including epidemiology, vector biology, and tick-borne diseases. A PhD student
and at least 6 undergraduates will be trained and instrumental in the completion of all aspects of the project
strengthening their preparation for future education and careers in the biomedical fields, including vector
biology, systematics, and zoonotic infectious diseases.